Unleashing CD8+ T Cells for TB Defense

PROJECT SUMMARY
This R21 application is based on exciting and novel preliminary data supporting the hypothesis that the
orphan nuclear receptor NR4A1 restrains the protective function of CD8+ T cells in tuberculosis (TB). We
found the NR4A1-/- mice control pulmonary infection with Mycobacterium tuberculosis (Mtb) significantly
better than wildtype (WT) mice. A similar effect was observed in WT mice treated with the NR4A1
antagonist DIM-C. In an adoptive transfer experiment, NR4A1-/- CD8+ T cells protected Rag1-/- mice from
aerosol Mtb infection better than transferred CD8+ T cells from NR4A1-/- or WT donors. This is remarkable
since prior studies found little or no protection from transferred WT CD8+ T cells, which was confirmed in
our experiment. Immunohistochemistry of lung TB lesions showed greater infiltration of CD8+ T cells in
NR4A1-/- mice compared to WT. Analysis of bulk RNA sequencing data from purified lung CD8+ T cells from
Mtb-infected mice identified upregulation of genes linked to cellular infiltrative capacity and cytotoxicity in
NR4A1-/- compared to WT hosts. If true, these findings will advance the field of cellular immunity in TB and
offer translation potential for NR4A1 inhibition as host-directed therapy. Expression of NR4A1 is induced by
T cell receptor signaling, which is the predominant mechanism for regulating its activity. We found that
NR4A1 mRNA is increased in the lungs of Mtb-infected mice, raising the fundamental question whether
NR4A1-regulated T cell tolerance supports a pathogen-permissive environment in TB. The goal of this R21
application is to confirm and extend key findings of the TB phenotyping, adoptive transfer, and DIM-C
treatment experiments, and to enhance these studies with more detailed outcome measures. We also plan
to perform single cell RNA sequencing of lung leukocytes and spatial transcriptomic studies in Mtb-infected
NR4A1-/- and WT mice as a first step towards identifying and prioritizing mechanistic hypotheses on which
to base a future RO1 proposal. Accordingly, we describe a research plan that is feasible to complete within
two years with the deliverables of an initial publication and a competitive RO1 application.

Public health relevance
PROJECT NARRATIVE This project studies host defense against tuberculosis. Based on promising early evidence, we will test the role of an immune cell factor called NR4A1 in the response to tuberculosis infection, and the effect of NR4A1 inhibition on tuberculosis outcomes. Results from this study will shed light on protective immunity and could result in the development of new treatments for this important disease.